Component A - The Muscular Dystrophy Surveillance, Tracking, and Research Network (MD STARnet) in Utah

PROJECT SUMMARY/ABSTRACT
The muscular dystrophies are disorders of muscle leading to progressive muscle weakness and reduced
quality of life and mortality due to respiratory and cardiac complications. In addition to motor, respiratory, and
cardiac complications, affected individuals and families have significant social, psychological, and cognitive
issues that are major gaps in understanding. As part of the MD STARnet project, we have identified cases of
all muscular dystrophy types in Utah, using a combination of unique resources available in our state. These
resources include our neuromuscular subspecialty clinics at the University of Utah and Primary Children’s
Hospital where we are the only muscular dystrophy specialty clinics in the intermountain west. Relevant
electronic health systems from the University of Utah and Intermountain Healthcare capture health care
encounters for the majority 95% of the Utah population. A unique electronic resource, the Utah Population
Database, links all individuals in Utah to multiple data sources, including extensive pedigrees, hospital records,
death certificates, birth certificates, ambulatory care and emergency room visits, and the Utah cancer registry.
The proposed project focuses on continuing our surveillance efforts using these resources and enhancing our
longitudinal surveillance for eligible muscular dystrophy cases in order to contribute to the understanding of
prevalence, comorbidities impacting health and well-being, and to address gaps in understanding including
issues psychological and neurobehavioral function and health-related quality of life. This information is critical
for future disease modifying therapeutic trials, and for the detection and care of those individuals who may not
currently have access to the standard of care.

Public health relevance
PROJECT NARRATIVE The muscular dystrophies are disorders of muscle leading to progressive muscle weakness, and reduced quality of life and mortality due to respiratory and cardiac complications. Our proposal seeks to continue to abstract the medical records of eligible muscular dystrophy cases to assess their prevalence in Utah, and as part of the consortium, study relevant gaps in understanding including issues psychological and neurobehavioral function and health-related quality of life.